Improving The Scripps Research Institute BSL3 Capabilities to Combat Viruses of Pandemic Concern

Project Summary/Abstract
The goal of the application “Improving The Scripps Research Institute BSL3 Capabilities To Combat Viruses Of
Pandemic Concern” is to renovate and upgrade The Scripps Research Institute (TSRI) current ABSL3 and BSL3
facilities. This will enhance TSRI research capabilities to combat RNA viruses of pandemic potential. TSRI has
~ 2,000 sf dedicated to ABSL3 and ~ 1,500 sf dedicated to BSL3. Currently, these facilities support research
projects from eight TSRI faculty whose combined areas of expertise cover research on RNA viruses of pandemic
potential, including Bunyavirales, Coronaviridae, Flaviviridae, Filoviridae and Togaviridae. In addition, the
facilities are supporting several projects sponsored by pharmaceutical companies. The specific studies have
strong translational components aimed at developing antiviral drugs and immunotherapeutics against these RNA
viruses. TSRI ABSL3 and BSL3 suites, located in the Molecular Biology Building (MBB), have been operating
24/7 since the last renovations in 2004. The existing mechanical systems have been maintained beyond
ASHREA equipment life expectancy for the La Jolla, Ca. coastal climate. In addition, the original design from
1985-87 has resulted in underutilization of ~160 sf in the ABSL3 and ~400 sf in the BSL3. To correct these
deficiencies, TSRI has completed a conceptual design with FPBA Architects & tk1sc Mechanical Engineers. This
plan includes replacing the aging HVAC systems of the ABSL3 and BSL3 space to increase airflow capacity with
N+1 redundancy and update the HEPA filtration system of the ABSL3. In addition, the project will modernize the
biocontainment suites by increasing holding capacity (ABSL3), creating a select agent isolation room (BSL3),
and installing a new sterilizer (ABSL3). The current ABSL3/BSL3 facilities lack imaging, cell sorting, and single
cell analysis capabilities. To remedy these deficiencies, we propose adding to the facility the EVOSTM Imaging
System, the SH800S Cell Sorter and the Chromium iX system. These improvements will help to address the
increasing demands by TSRI faculty for ABSL3/BSL3 space, time and improved functional capabilities, while
ensuring the highest level of safety during daily operations of the facility. Moreover, research activities proposed
under the Antiviral Program for Pandemics (APP) U19AI171443 AViDD Grant Application, will greatly benefit
from the proposed improvements to the current TSRI ABSL3 and BSL3 facilities. The project will be managed
by a well-integrated and highly qualified team, including leaders from Facilities Construction and Engineering,
the Institutional Animal Program and Resources, EHS and Biosafety, the Executive VP Office, and investigators
directly involved in ABSL3/BSL3 research activities. In addition, the application has the unwavering support of
the TSRI leadership.